FREDERICAMYCIN: PRACTICAL SYNTHESIS AND ANALOGS

In 1982 the structure of fredericamycin was deciphered. While fredericamycin exhibits antibiotic properties, it has gained greatest attention for its in vitro and in vivo activity against a variety of anticancer screens and is regarded as a possible candidate for clinical trials. The objectives of this project are 1) to effect an expeditious synthesis of fredericamycin which can generate practical quantities of the material; 2) to utilize this synthesis to prepare analogs of fredericamycin selected to probe structure-activity relationships responsible for fredericamycin's biological activity and 3) to use the synthesis of fredericamycin as a vehicle for the further examination of the scope and limitations of lateral metalation as a general synthetic method for the preparation of pharmaceuticals and other organic materials.